Osmotic Regulation of a Peptide Ligand-Mediated Signaling

Abstract
Cells in a multicellular organism constantly communicate by ligand-receptor-mediated signaling to
coordinate their growth, development, and adaptation to the environment. The peptide ligands-triggered
signaling is the most abundant in this network in humans, dysregulation of which contributes to many prevalent
human diseases. However, knowledge of how the peptide ligand-triggered signaling is regulated by the
environment remains incomplete. We study a classical peptide ligand-receptor-mediated signaling pathway that
regulates the epidermal stomatal development in Arabidopsis thaliana, a naturally simplified and experimentally
accessible system. Stomata are micropores on the aerial surface of plants that facilitate gas exchange with the
environment. Stomatal development is flexibly adjusted under variable environmental conditions to optimize plant
adaptation, making it an attractive system for studies on environmental regulation of peptide ligand-triggered
signaling pathways. Upstream of the stomatal signaling pathway are a group of secretory ligands named
Epidermal Patterning Factors (EPFs), many of which are highly responsive to environmental cues. We found
that osmotic stress caused a dramatic reduction in stomatal density. Interestingly, the transcript of a putative
EPF ligand is preferentially induced under osmotic stress. Compared to wild-type plants, the epf mutants produce
more stomatal precursor cells under osmotic stress. With these new findings, we hypothesize that osmotic stress
inhibits stomatal development via enhancing the candidate EPF ligand-triggered signaling. Our study and others
have previously indicated that distinct EPF-triggered signaling pathways target different steps of the stomatal
developmental process. The specificity is, at least partially, due to the precise spatiotemporal expression of a
particular EPF ligand and the differential subcellular behavior of the receptor kinases including ERECTA-LIKE 1,
that transduce the EPF signaling. This MIRA proposal aims to comprehensively evaluate the osmotic stress-
induced EPF ligand-triggered signaling pathway by addressing the following three questions: 1) Elucidate the
osmotic regulation of the transcription of the candidate EPF gene; 2) Dissect the osmotic regulation of the
stomatal receptor complex; 3) Identify the targets of the osmotic stress-induced EPF signaling pathway.
Completion of this work is likely to provide valuable insight into our understanding of osmotic regulation of
organism development via peptide ligand-triggered signaling pathways.

Public health relevance
Public Health Relevance Statement Peptide ligand-mediated signaling is integral to the development of multicellular organisms and their adaptation to the environment, dysregulation of which contributes to many prevalent human diseases, including cancer, diabetes, immune-related diseases, and neurological disorders. The proposed study aims at elucidating the osmotic regulation of a classical peptide ligand-mediated signaling pathway. It involves mechanisms of transcriptional regulation, protein subcellular behaviors, protein stability regulation, and cell-state transitioning, all of which are clearly related to the studies of human signaling pathways.